SEER-NLMS, a Linkage of the Surveillance, Epidemiology and End Results (SEER) and

The purpose of this Interagency Agreement (IAA) is to authorize the transfer of funds appropriated for the Surveillance Research Program (SRP) of the Division of Cancer Control and Population Sciences (DCCPS), National Cancer Institute (NCI) to the U.S. Census Bureau to facilitate the access of extramural investigators to the linked SEER-NLMS resource. The National Cancer Institute (NCI) agrees to provide funding to the Census Bureau Demographic Integration Division to obtain the following Census Bureau services: I. Update the SEER-NLMS linkage to match incident cancer cases in the SEER 18 Research File, excluding Alaska, through diagnosis year 2009 with CPS March Supplement data from 1973 to 2008. a. The first step is to finalize the match of incident data from SEER 17 registries, excluding Alaska, through diagnosis year 2007 to CPS supplements through 2007. The process requires manual review of equivocal computer algorithm-based matches performed at the Census Bureau offices in Suitland, MD at the Census Bureau National Data Processing Center in Jeffersonville, IN. The National Institute on Minority Health and Health Disparities has provided co-funding to complete this task on or before November 30, 2011. b. The second step is to finalize the match of incident data from SEER 18 registries excluding Alaska through diagnosis year 2009 to Current Population Survey March Supplements through 2008. For the first time, all incident cases within Greater Georgia that are part of the Research File will be included in SEER-NLMS. The target is a match to all Greater Georgia cases diagnosed during 2000-2009. The inclusion of Greater Georgia will increase case counts of Blacks and rural residents in the SEER-NLMS database. This process requires completion of a computer algorithm-based match at the Census Bureau in Suitland, MD followed by manual adjudication at the Census Bureau National Data Processing Center in Jeffersonville, IN. The NCI Center to Reduce Cancer Health Disparities has provided co-funding to complete this task by May 31, 2012. II. Performance of routine and complex analyses of the SEER-NLMS linked data within requested timeframes. Prepare analytical tables using the most recently available linked data and assistance in the design and preparation of papers, reports and presentations.